STUDIES OF HORMONE ACTION IN PATIENTS WITH ALTERED G PROTEIN FUNCTION

Work has focused on elucidation of the clinical implications of molecular defects in the gene (GNAS1) that encodes the a chain of the stimulatory G protein of adenylyl cyclase (Gsa).